Mechano signals regulating tendon and ligament homeostasis

ABSTRACT
Mechano-stimulation in the musculoskeletal system plays a major role in the homeostasis of all tissues and
organs. Particularly in tendons, the proper physiologic exercise load has an anabolic effect with increased
tenogenic gene expression in humans; however, the molecular mechanisms that sense mechanical stimuli
remain unclear. Piezo1 is a mechano-sensitive ion channel involved in mechano-sensing in various organs and
tissues; however, it has not yet been examined in tendons or ligaments. In mice, the R2482H mutation of
Piezo1 is an active form mimicking a gain-of-function (GOF) PIEZO1 variant found in humans. To test the
potential effects of Piezo1 in physical performance, we generated systemic GOF Piezo1 (Piezo1systemic-GOF)
mice, muscle-specific GOF Piezo1 (Piezo1muscle-GOF) mice, and tendon-specific GOF Piezo1 (Piezo1tendon-GOF)
mice and found that the jumping power of Piezo1tendon-GOF mice as well as Piezo1systemic-GOF mice at 12-weeks-
old was ~1.6 times greater than in both wild-type mice and Piezo1muscle-GOF mice. Consistent with this,
significantly altered macroscopic and histological phenotypes were observed in the tendons of Piezo1tendon-GOF
mice with increased tendon-specific gene expression. We also found that upregulation of aging related
ossification gene expression was significantly reduced in aged Piezo1tendon-GOF mice. This suggests that
constitutively enhanced PIEZO1 activity promotes physical performance via tendons/ligaments. These
preliminary data underlie our hypothesis that PIEZO1 acts as a critical mechano-sensor in tenocytes,
maintaining and promoting tendon/ligament functions by orchestrating tendon/ligament-specific gene
expression. To test this hypothesis, we will pursue the following Aims: Aim 1: Analyze the function of
Piezo1 in human and mouse tendon homeostasis and aging. We will examine the function of Piezo1 in
tenocytes for tendon homeostasis and in aging by morphological, histological and gene expression analysis of
tendons from Piezo1tendon-GOF mice and tendon specific loss of function (LOF) Piezo1 (Piezo1tendon-LOF) mice at
different aging points. We will also test the role of PIEZO1 in human tenocytes by transcriptome analysis with
PIEZO1 siRNA knockdown or a small molecule PIEZO1 activator. Aim 2: Evaluate the role of Piezo1 in
tenocytes on physiological performance and exercise in mice. We will evaluate the role of Piezo1 in
tenocytes to potentiate physical performance using postnatally induced tendon specific gain of function and
loss of function Piezo1 mice at different ages. Thereafter, we will examine whether this physical ability could be
strengthened by physiological exercise inducing anabolic mechanical stimulation. Aim 3: Analyze the
biomechanical properties of tendon that are regulated by Piezo1. We will uncover how the kinetic energy
for the enhanced jumping ability of the Piezo1tendon-GOF mouse is produced by biomechanical analysis of tendon
stored energy and muscle contraction power. Completion of these aims will support the concept that Piezo1
could be a therapeutic target to maintain or enhance structure and function of the musculoskeletal system.

Public health relevance
PROJECT NARRATIVE We will examine the function of Piezo1, a mechanosensory molecule, to clarify an unexplored critical role of the tendon/ligament in tissue homeostasis and exercise ability. This will open up a new avenue for basic physiology and genetic research and contribute to innovating novel medical strategies for the many common musculoskeletal disorders that result from tendon/ligament injuries or aging-related degradation.